Developing a patient-centered intervention to improve exercise adoption and adherence among post-9/11 women Veterans

Background: Women Veterans often report little or no exercise after leaving military service. Regular exercise
contributes to significant benefits in physical and psychological health, including risk reduction for several
chronic conditions, such as diabetes and cardiovascular disease. As such, women Veterans’ diminished
exercise contributes to their increased risk for significant health conditions and can have a cumulative negative
impact on their long-term health (e.g., obesity, cardiovascular disease, hypertension). Women Veterans lack
access to effective approaches for increasing exercise, such as behavioral interventions (e.g., goal setting),
that are tailored to their needs and can mitigate significant, preventable health conditions among this Veteran
population. Psychological skills training (PST) interventions use evidence-based strategies (goal setting,
imagery, self-talk, relaxation) to increase exercise participation and satisfaction. In the proposed project, we
will adapt evidence-based strategies used in PST interventions to tailor a novel PST intervention known as
STRIVE (Skills Training to Increase Veteran Exercise) to increase exercise adoption and adherence among
women Veterans from the post-9/11 era.
Significance/Impact: The post-9/11 era is the largest cohort of women Veterans and is rapidly growing. To
mitigate the impact of significant, preventable health conditions among women Veterans and the subsequent
burden on the VA healthcare system, approaches are needed to meet the distinct needs of this Veteran
population. This proposal addresses (1) several objectives within the VA's Strategic Plan focused on women
Veterans and improving their access to tailored health care and (2) HSR research priorities focused on women
Veterans’ health care needs and interventions following military service. The proposed project is also timely
and aligned with the recently signed Executive Order prioritizing research on women’s health issues. Findings
will contribute to VA’s current exercise initiatives and efforts to tailor women Veterans’ health care.
Innovation: Psychological skills training (PST) interventions have been effectively used and implemented in a
variety of settings, such as the military, and have been found to increase exercise. PST interventions can also
increase self-efficacy, which is one of the strongest determinants of consistent exercise. However, despite the
demonstrated effectiveness of PST interventions on increasing exercise and self-efficacy, the application of
PST interventions to increase exercise among women Veterans remains largely unexplored.
Specific Aims: This study will determine exercise perceptions and support needs among women Veterans,
(Aim 1), iteratively tailor a PST-based intervention protocol for exercise among women Veterans (Aim 2), and
preliminarily pilot test the PST intervention for exercise to assess feasibility and acceptability (Aim 3).
Methodology: This is a multimethod study. In Aim 1 we will use qualitative interviews to elicit perceptions of
exercise behaviors from women Veterans (N=30). In Aim 2 we will assemble an advisory group (N=6-8) of VA
clinicians and administrators to elicit input on how to tailor a PST-based intervention protocol for exercise for
women Veterans. In Aim 3 we will conduct a preliminary pilot test using a sample of women Veterans (N=12)
to qualitatively and quantitatively assess the feasibility and acceptability of the intervention developed in Aim 2.
Implementation/Next Steps: We will develop implementation strategies in Aim 2 to facilitate broader testing,
scalability, and future implementation of the STRIVE intervention. These strategies will be tested and refined in
the planned future Merit Award application that will test STRIVE in a randomized controlled trial. More broadly,
findings from Aim 1 and the implementation plan in Aim 2 can be used to augment existing services, such as
the VA MOVE! Program or Whole Health. Adapted evidence-based strategies to promote exercise among
women Veterans can also be implemented into clinical services (e.g., gynecology and primary care visits) and
VA services that support women Veterans.

Public health relevance
As women Veterans transition out of the military, they often struggle to sustain regular exercise. Lack of exercise increases women Veterans’ risk for significant health conditions, such as obesity or cardiovascular disease. Psychological skills training (PST) interventions use evidence-based strategies (goal setting, imagery, self-talk, relaxation) to increase exercise participation and satisfaction. PST interventions are effectively used to increase performance in a variety of settings, such as the military, and have been found to increase exercise. However, they have been largely ignored for exercise promotion in the Veteran population. The proposed project will use the intervention mapping approach to adapt evidence-based strategies and tailor a PST intervention known as STRIVE (Skills Training to Increase Veteran Exercise) to increase exercise among women Veterans. STRIVE will also be preliminarily pilot tested to assess feasibility and acceptability. Findings will contribute to VA’s current exercise initiatives and efforts to tailor women Veterans’ health care.